Improving Access and Linkage to Substance Use Treatment for Formerly Incarcerated Persons Applying a Complex Systems Approach

PROJECT SUMMARY
This project aims to enhance the health and well-being of individuals transitioning from correctional facilities to
community settings by addressing barriers to accessing and engaging in medications for opioid use disorder
(MOUD) treatment using an innovative complex systems approach. A complex systems approach aims to
address social determinants of health and expressly acknowledges that achieving health equity requires more
than just individual interventions; it necessitates systemic changes that improve coordination, communication,
and resource allocation across various organizations and agencies involved in the reentry process. This
approach focuses on transforming the interconnected components of the reentry system to create a supportive
environment that facilitates continuous and effective access to MOUD treatment.
Specific aims include: 1) examination of the structure and function of organizational networks and strength of
relationships among organizations that provide reentry and linkage services for MOUD treatment, 2) provider
perspectives on how network connectivity and multi-level interactions impact linkage for MOUD treatment, and
3) perspectives of formerly incarcerated individuals with current or prior illicit opioid use on interactions with the
complex reentry system for linkage to MOUD treatment.
The research design employs a multi-method approach, combining quantitative and qualitative data collection
and analysis. Quantitative data will be collected from organizational leaders and reentry service providers
using a network survey consisting of a network inventory and a relational coordination assessment. Qualitative
data will be gathered through in-depth interviews with reentry service providers and formerly incarcerated
individuals, focusing on their experiences with access and linkage to MOUD treatment. The project will utilize
complex systems and organizational network analysis to understand the structure and dynamics of reentry
organizations involved in MOUD linkage and treatment.
The findings will inform the development of policy recommendations and intervention strategies aimed at
improving the coordination and integration of reentry services. This research is highly relevant to the mission of
the National Institute on Drug Abuse (NIDA) as it addresses critical gaps in the provision and care continuity of
MOUD, which is essential for reducing opioid-related morbidity and mortality among populations with criminal
legal system involvement. By focusing on the systemic and organizational factors affecting MOUD access, this
project seeks to create a more effective and equitable reentry system that supports the health and recovery of
formerly incarcerated individuals.

Public health relevance
PROJECT NARRATIVE This research is critically relevant to public health as it addresses the significant gaps in treatment access and linkage to medications for opioid use disorder (MOUD) for formerly incarcerated individuals. By focusing on the reentry process and its associated challenges, the study aims to shed light on how the complex interplay of various organizational and interpersonal factors within the reentry system affects the continuity of MOUD treatment. The findings will inform pathways to enhance coordination and streamline service delivery during reentry, ultimately improving the health and well-being of individuals transitioning back into the community from incarceration.